SEQUENTIAL HORMONAL THERAPY FOR ANDROGEN INDEPENDENT PROSTATE CANCER

The purpose of this single center pilot study is to determine the effectiveness of sequential hormonal therapy wth aminoglutethemide and hydrocortisone in patients with androgen-independent prostate cancer currently treated with bicalutamide.